Phospho- and natural-variant regulation of heterotrimeric G protein signaling

Project Summary/Abstract
Numerous cellular signaling pathways of critical importance to organism health rely on heterotrimeric G
protein signaling. Heterotrimeric G proteins are composed of Gα, Gβ, and Gγ subunits. Classically, ligand binding
to transmembrane G-protein-coupled-receptors (GPCRs) elicits conformational changes that lead to exchange
of GDP for GTP on the Gα subunit, and resultant separation of Gα from the Gβγ dimer, either or both of which
then signal to downstream effector proteins until intrinsic GTPase activity of Gα restores the heterotrimeric state.
G proteins participate in numerous signaling cascades in both metazoan and plant systems and many aspects
of G protein signaling are remarkably conserved across this evolutionary divide. The overarching goal of my
research is to harness the simpler G protein complement of the model plant, Arabidopsis thaliana, to reveal how
heterotrimeric G protein genotypes and molecular phenotypes control cellular signaling cascades, and thus
whole organism consequences. Our laboratory has been a leader in plant heterotrimeric G protein signaling for
>25 years; we have elucidated G protein signaling via methods ranging from single cell electrophysiology to
imaging to -omics approaches, to sophisticated whole organism phenotyping and genome-phenome analyses.
This proposal focuses on two types of molecular phenotypes – phosphorylation and natural variation -- and
their attendant consequences on G protein biochemistry, cellular signaling, and whole organism vitality. We have
ascertained that Gα phosphorylation at sites conserved across mammalian and plant Gαs can dramatically
impact the G protein cycle. In Theme 1, we plan to utilize >60 Gα phosphomimic and phosphonull lines we have
created to determine the phenotypic consequences of Gα phosphostatus. We will assess how phosphorylation
changes Gα molecular partners (i.e. how phosphorylation biases signaling), and phenotypic consequences. We
propose that phosphorylation “diversifies” the number of functionally distinct Gα proteins, resolving an apparent
mismatch between the number of G protein subunits vs. the much greater numbers of GPCRs and phenotypes.
Some G protein mutations are known to cause disease. Many more are statistically “associated’ with disease
outcomes, but whether they actually cause disease is difficult to ascertain due to the high heterozygosity of
humans, low phenotypic penetrance, and inaccessibility of humans to experimentation. Arabidopsis is naturally
inbred and can be genetically manipulated with ease. In Theme 2 research, we plan to determine the impact of
natural missense single nucleotide variants (SNVs) on Gα biochemistry. We will next experimentally reveal in
Arabidopsis the phenotypic consequences of these mutations. Then we will ask whether, in nature, deleterious
SNVs are accompanied by other SNVs in Gα that forestall the negative consequences of the missense
mutations, in positive “intrageneic epistasis”. Next, we will assess intergenic epistasis between Gα variants and
regulatory proteins. Demonstration of such phenomena is both mechanistically revealing and will allow medical
science to better ascertain whether or not an individual with a given Gα SNV is actually predisposed to disease.

Public health relevance
Project Narrative Many human infectious and genetic diseases disrupt G protein pathways, which constitute a conserved eukaryotic signaling mechanism. The proposed research will employ a highly tractable system to provide a comprehensive understanding of the regulation of heterotrimeric G protein biochemistry and signaling by subunit phosphorylation and natural variation in G protein sequence, and will thus identify specific regulatory paradigms that strengthen or impair the G protein cycle, heterotrimer interactions, subcellular localization, and coupling with other proteins. Results obtained will identify new G protein conformations for therapeutics, and will distinguish disruptive and benign natural variants, thereby identifying conditions and opportunities wherein targeted interventions should and can be prioritized to repair dysregulated aspects of G protein signaling while simultaneously avoiding impairment of other G protein functions and phenotypes.